Phase 1 Clinical Trial to Assess the Pharmacokinetics, Safety and Tolerance of a Zanamivir Transdermal System in Healthy Subjects

Abstract
Yearly influenza epidemics strike millions of people, resulting in up to 500,000 deaths. Fatalities caused by most
seasonal influenza viruses is <0.03%, with significant mortality in the young and elderly populations. Presently,
influenza treatment is only partially effective, and some influenza strains are resistant to the currently marketed
therapeutics, adamantanes and the neuraminidase inhibitor Tamiflu®), and even the recently approved cap-
dependent endonuclease inhibitor baloxavir marboxil (Xofluza®). Zanamivir (ZAN, Relenza®), remains highly
active against oseltamivir-resistant influenza strains, however, its therapeutic impact is severely limited by its
route of administration, oral inhalation, which renders it unsuitable for patients with compromised respiratory
systems. Therefore, the development of a novel delivery alternative for ZAN will address a significant unmet
medical need. Transdermal drug delivery offers several improvements over other delivery systems. The drug
directly enters the systemic circulation, avoiding syringe needles, and could allow large numbers of patients to
be reached during an influenza pandemic outbreak. ZAN itself cannot cross the human skin barrier at therapeutic
rates, however, microarray-enabled transdermal delivery is an elegant, efficient, and painless method for
increasing the skin permeation of many drugs, including ZAN. Our novel drug-device combination product, TSR-
066, consists of a swellable microarray patch (MAP), which continuously delivers ZAN over 5 days. This delivery
approach for ZAN will expand its reach into patient groups for which Relenza® is contraindicated.
Based on the well-established preclinical and clinical safety of ZAN, TSRL has achieved an agreement with the
FDA that TSR-066 can be developed using a 505(b)2 regulatory strategy. Upon collection of sufficient data to
support the change in the route of administration under our ongoing SBIR grants, TSRL plans to submit an
investigational new application (IND) in 2024. This Fast-Track SBIR will allow for the planning and conduct of a
Phase 1 clinical trial to assess the pharmacokinetics, safety and tolerance of TSR-066 in healthy subjects. During
the Phase I portion of the grant, we will assemeble the clinical development team, develop the clinical protocol,
investigator brochure, consent form, case report form, budget, and manual of operations. These documents will
be prepared through collaboration with BIA Clinical Group, LLC and reviewed by our scientific collaborators, the
clinical research unit utilized for the study, and participating Clinical Research Organizations. The Phase II
portion of the grant will be the actual conduct of the trial. We have formed a collaborative network of researchers
and drug development specialists that will allow us to successfully complete the proposed research plan.

Public health relevance
Project Narrative TSRL is developing a novel transdermal delivery product of zanamivir for the treatment and prevention of the flu. The proposed research plan will permit the planning, design, and preparation of all the documents necessary for the Phase I Clinical Trial, as well as its ultimate conduct.